ACTG 362: EFFICACY OF AZITHROMYCIN PROPHYLAXIS AGAINST MAC DISEASE

To compare the time to development of MAC disease in subjects receiving azithromycin to those receiving placebo, among subjects who have had an increase in CD4 count from <50 to >100.